PSYCHOPHARMACOLOGY OF SEPARATION ANXIETY DISORDER

The overall goal of the proposed study is to investigate the efficacy of two psychopharmacological treatments in the management of children with Separation anixiety disorder. Youngsters between the ages of 6-16, diagnosed as having Separation anxiety disorder, will receive psychotherapy for 4 weeks. Those who do not improve with brief psychotherapy will be assigned randomly to imipramine, diazepam, or a placebo, for a six week period. Daily dosages will not exceed 5 mg/kg for imipramine, and 30 mg/d for diazepam. The efficacy of the two agents compared with a placebo will be examined, as well as the relative efficacy of the two drugs, in the reduction of separation anxiety.